FRONTIERS IN SCIENCE CONFERENCE

? DESCRIPTION (provided by applicant): Frontiers in Science Conference synergizes with the NICHD-funded Pediatric Scientist Development Program focusing on pediatric residents-in-training and encouraging careers in academic pediatrics as future physician- scientists. This is a renewal for years 6-10.

Public health relevance
PUBLIC HEALTH RELEVANCE: This Frontiers in Science (FIS) Conference supports residents-in-training to become future pediatric physician- scientists.